Evidence-based Interventions to Enhance Outcomes among Struggling Readers

PROJECT SUMMARY/ABSTRACT
While considerable knowledge has been accumulated on improving reading for students with reading disabilities in the
primary grades, reading interventions conducted with middle-grades (i.e., grades 3-6) have been rare and have
typically evidenced low impacts, even when more intensive interventions are provided for increasingly longer
durations. One hindrance to extant interventions has been the narrow focus on reading problems without addressing
non-academic (e.g., self-regulation, socioemotional) factors known to also affect learning. Thus, investigations of the
efficacy derived from integrating additional components into standard reading skills interventions are necessary.
Anxiety represents a particularly salient target for such an approach, as it is among the most commonly reported
mental health issues of childhood, and significant associations have been found between anxiety and academic
outcomes. Further, an overwhelming number of children who are struggling to read or who fail to respond to reading
interventions report elevated anxiety. The purpose of this proposal is to evaluate an integrated program designed for
middle-grade readers and comprised of evidence-based practices for the treatment of anxiety and reading difficulties.
A pilot study of this program, conducted with 36 students randomized to treatment and control conditions,
demonstrated its feasibility and positive effects on anxiety outcomes. The proposed multi-site RCT will extend this
work by comparing the combined reading and anxiety intervention with a reading-only condition and a control
condition. Struggling readers will be included in this study and will receive two years (4th-5th grades) of intervention.
The study will assess efficacy of the interventions at reducing anxiety and improving reading at post-intervention and
6-month follow-up (Aim 1). This project significantly enhances extant research on interventions for struggling reading
by examining mechanisms of action associated with augmented outcomes among students who receive the combined
intervention (Aim 2), and by determining potential moderators of intervention effects (Aim 3). In all, 300 ethnically
diverse students will be recruited across two sites. A multi-informant (student, parent, teacher), multi-method (e.g.,
survey, standardized test, experiential sampling) assessment will be used. Relevance of this project lies in the
determination of whether the inclusion of anxiety management skills enhances existing intervention outcomes for
struggling readers in the upper elementary grades (concurrently/longitudinally). Examination of contextual and
mitigating factors are further relevant for understanding the complex etiology of response to intervention among
struggling readers. This project represents translational research that directly informs the practice community (e.g.,
clinicians, teachers) by identifying novel instructional practices that can be aggregated to more effectively influence
student outcomes. By providing socioemotional skills training with a reading intervention using a school-based
delivery model, this work has the potential of reducing disparities in mental health outcomes by reaching students of
diverse backgrounds (e.g., ethnicity, SES) who would be otherwise less likely to receive such services.

Public health relevance
PROJECT NARRATIVE Despite decades of research on reading disabilities, little is known about improving reading in the middle grades (i.e., grades 3-6) and advancements have been hindered by the narrow focus on reading problems alone without acknowledgement of non-academic factors shown to affect learning (e.g., child self-regulation). This proposal employs a highly innovative approach aimed at improving intervention outcomes through the integration of evidence-based practices for addressing reading, as well as self-regulation/socioemotional skills, difficulties known to occur in a substantial percentage of struggling readers and to negatively influence academic performance. This project represents translational research that directly informs the practice community (schools, clinicians, teachers, parents), by identifying novel instructional practices that can be aggregated to more effectively influence student outcomes and reduce disparities in academic and socioemotional domains.